Training Program in Neuroscience

PROJECT SUMMARY
This is the second renewal of Mount Sinai's Jointly Sponsored Institutional Predoctoral T32 Training
Program in Neuroscience. The objective of the Training Program is to provide rigorous, broad-based,
individualized and multidisciplinary training to Year 1 and 2 predoctoral students in basic, translational and
clinical neuroscience research, thereby enhancing the ability of our trainees to acquire critical skillsets
necessary for high-quality doctoral dissertation research and a productive and impactful career in the science-
related workforce. To accomplish this, the Training Program leverages the intimate association between the
Mount Sinai Hospital and Health System, the Icahn School of Medicine at Mount Sinai and Mount Sinai's
Graduate School of Biomedical Sciences, physically embedded together under one leadership, to expose
trainees to the enormous breadth of basic, translational and clinical scientific approaches and model systems
represented by an outstanding training faculty, ranging from structure/function analysis of individual synapses,
to computational modeling of gene, protein and connectivity networks in healthy and diseased brains, to
behavioral, electrophysiological and imaging studies of a variety of organisms, including humans. Mount Sinai
has undergone an enormous expansion in basic and clinical research infrastructure, neuroscience faculty
recruitment and a 3-fold increase in applications to the Neuroscience PhD program. Thus, seven training slots
per year are requested. Our trainees participate in an integrated program of Core courses (spanning genes,
molecules, cells, synapses, circuits, systems, behaviors and brain pathophysiology) and includes a course with
direct patient contact. Courses are team-taught by an exceptional faculty using different teaching styles,
including flipped classrooms and other approaches. Additional first-year courses include Responsible Conduct
in Research, Rigor and Reproducibiity, an intensive Biostatistics course (with a parallel lab in R-programming)
a Journal Club/WIP and research rotations. By the end of the first year, trainees select a thesis lab, and during
their second year, commence dissertation research while taking at least two Advanced Electives from a large
number of courses offered across the Institution. This allows each trainee to customize their coursework to
their particular research and training goal needs. Trainees in our program also benefit from numerous activities
that enhance their research experience, including science theme-based Clubs, seminars, career development
opportunities, teaching and peer-mentoring activities, an annual retreat and other cohesion-building events.
This Neuroscience Training Program T32 is essential to Mount Sinai's mission of providing fundamental
neuroscience research training to our students, and serves as the principal research training, mentoring and
financial engine driving specifically early-stage predoctoral students seeking a PhD in Neuroscience.

Public health relevance
PROJECT NARRATIVE The Neuroscience Training Program at Mount Sinai provides rigorous, broad-based, individualized and multidisciplinary training to Year 1 and 2 predoctoral students in basic and translational neuroscience research, including research with a disease-focus. The goal of the Program is to enhance the ability of our trainees to acquire critical skillsets necessary for high-quality doctoral dissertation research and a productive and impactful career in the science-related workforce.